Glucocorticoids, ocular hypertension and glaucoma

Glucocorticoids (GCs) are commonly used anti-inflammatory and immunosuppressive therapeutic agents for a
plethora of diseases and conditions. Over 1% of our population receives GC prescriptions annually. Despite
the very broad and potent anti-inflammatory effects, prolonged GC therapy can cause serious side effects,
including damage to the eye. Between 30-75% of individuals receiving prolonged GC therapy develop GC-
induced ocular hypertension (OHT), which if unrecognized can lead to iatrogenic open-angle glaucoma and
permanent vision loss. Despite recognition of this significant GC side effect for more than six decades, we still
do not understand the reason for differences in susceptibility to GC-induced OHT or the mechanism(s) of
action responsible for GC-OHT. We have previously shown that the alternative spliced dominant negative
isoform of the glucocorticoid receptor (GRb) inhibits GC activity in cultured human TM cells. TM cells isolated
from glaucoma donor eyes (GTM) have low GRb levels and are therefore more sensitive to GCs. Although a
number of studies have examined the DEX-induced transcriptome in TM cells and tissues, there is no
indication which of the differentially expressed genes or molecular pathways are involved in GC-OHT. Several
studies have shown that susceptibility to develop GC-OHT is genetically inherited, but no genes have been
definitively linked to GC-OHT. Our overall hypothesis is that GC-OHT is: (a) determined by the ratio of
endogenous GRa to GRb expression in the TM; (b) mediated by specific molecular pathways that can be
differentiated from GC-responder and non-responder eyes; and (c) genetically determined so that GC-OHT
genes can be mapped and identified. This overall hypothesis will be tested in 3 specific aims. Specific Aim #1:
Determine the role of endogenous GRb in regulating GC-OHT in human anterior segment ex vivo perfusion
culture and in vivo in mice. Specific Aim #2: Determine the TM transcriptome in GC-OHT resistant and
sensitive strains of mice and in anterior segment perfusion cultured human eyes in order to identify the
molecular pathways that are responsible for GC-OHT. Specific Aim #3: Map and identify the genes
responsible for GC-OHT using QTL of the BXD recombinant inbred mouse lines. This research is innovative
in that we will evaluate the role of endogenous GRb in mouse strains (with our new mouse model of GC-OHT)
and in ex vivo perfusion cultured human anterior segments that differ in sensitivity to GC-OHT, use mouse
strains and human perfusion cultured anterior segments that are differentially responsive to GC-OHT to
molecularly dissect the pathway responsible for GC-OHT, and map GC-OHT genes using BXD recombinant
inbred mice. This work is essential and significant because our experimental results will help determine the
role of endogenous GRb in regulating responsiveness to GC-OHT, the molecular mechanisms responsible for
GC-OHT, and the best and most effective way to predict steroid responders, which still is an important unmet
clinical need as GC-OHT is becoming increasingly prevalent.

Public health relevance
Narrative The broad use of anti-inflammatory steroids in millions of patients can cause elevated pressure inside eyes leading to glaucomatous loss of vision in susceptible individuals, which is a clinically significant problem. This steroid response is found in most glaucoma patients and is an important risk factor in the development of glaucoma. We have discovered a likely mechanism and are identifying genes responsible for this steroid responsiveness, which may play a major role in the development of glaucoma.